2024 Plasminogen Activation and Extracellular Proteolysis Gordon Research Conference and Gordon Research Seminar

Summary
Partial support is requested for graduate students and post-doctoral fellows, and junior and midcareer faculty
to participate in the Gordon Research Seminar and Conference (GRS/GRC) entitled “Plasminogen Activation
and Extracellular proteolysis”, which will be held in Ventura, CA on February 17-18 and 18-23, 2024,
respectively. This will be the 19th GRC, as the conference has been held continuously every two years since
1990. The theme of the 2024 GRC will be Cutting-Edge Research, Emerging Therapeutics, and Clinical
Outcomes with major focus on mechanisms and therapeutic targets of extracellular proteolytic enzymes,
including plasmin(ogen), plasminogen activators, coagulation proteases, matrix-metalloproteinases (MMPs),
their precursors and effectors. Recent data suggest that the expression of proteases with circulation and the
extravascular compartments of tissues is tied to numerous pathological processes. Our invited speakers and
discussion leaders will present their recent and emerging work across a spectrum of basic science and clinical
topics, including cardiovascular disease, aging, cerebrovascular function, metabolic diseases, musculoskeletal
and neurodegenerative diseases, cancer, infection and immunity, tissue remodeling and regeneration, as well
as trauma. Priority will be placed on highlighting both the role these proteins play as disease modifiers as well
the utility of employing or targeting these factors for therapy. One of the major goals for the 2024 GRC meeting
is translating basic research into clinical outcomes. Attendees will be selected by invitation and from
applications submitted online. They will be chosen to represent not only a diverse spectrum of research, but a
strong emphasis will be on diversity of participants, equity of opportunity, and inclusion of individuals across all
demographic metrics. There will be participation of women, scientists from underrepresented groups, and
people with disability as session leaders and speakers. An intended strength of this meeting will be the
interaction and networking of the young scientists in the field, with the discussion leaders and the speakers.
The associated GRS, which is a much younger feature of the conference, will provide a unique opportunity for
trainees and scientists to share in the GRC experience. This two-day seminar will be organized by Graduate
Students and Postdoctoral Fellows with the support of leading researchers and the GRC Chairs and will allow
junior researchers within the field of plasminogen activation, MMP, and extracellular proteolysis to come
together to discuss their current research, while building informal networks with their peers that may lead to a
lifetime of collaboration and scientific achievement.

Public health relevance
Narrative Plasminogen activation, MMPs, and extracellular proteolysis are rapidly advancing research areas as they intersect with basic science and clinical research. Critical roles for extracellular proteases are identified in many disorders related to cardiovascular disease, stroke and neurological disorders, aging, cancer, musculoskeletal and metabolic diseases, as well as infectious diseases. It is increasingly evident that research in this area is critical for the development of novel strategies and agents to treat these diseases.